Career Enhancement Program

PROJECT SUMMARY
The Investigators assembled in the DF/HCC Myeloma SPORE have a substantial long-term record in
mentorship and development of junior faculty working in translational myeloma research. The goal of the
Career Enhancement Program of our Myeloma SPORE is to build upon this record and establish a formal
process for the identification, selection, funding, and mentoring of individuals pursuing careers in the study of
the basic and clinical aspects of myeloma. These awards will facilitate the development of physicians,
physician scientists, clinical investigators, and scientists in training within the Myeloma SPORE Program
towards faculty status. Thus, candidates will be junior faculty or fellows and postdoctoral fellows within the
various training programs across DF/HCC and participating institution. Our Career Enhancement Program has
been extremely successful in the previous funding period, with three investigators now having independent
funding and eight have attained independent faculty positions and promotions as a direct result of this
Program. It is our goal to continue to attract, mentor, and assure the success of several candidates within the
timeframe of this SPORE. Success will be defined as the development of physician/scientists in training
towards careers as independent investigators.

Public health relevance
PROJECT NARRATIVE The Career Enhancement Program is intended to mentor young investigators and attract these next generation researchers to translational Myeloma research.